Mobilizing TAP-independent CD8 T cells through non-canonical cross-presentation

PROPOSAL SUMMARY
Major histocompatibility complex class I (MHC-I) molecules present peptides at the cell surface to CD8 T cells.
The transporter associated with antigen processing (TAP) is a heterodimeric molecule of TAP1 and TAP2 that
lies at the center of a macromolecular peptide loading complex tasked with loading and folding MHC-I molecules
with peptides. TAP shuttles cytosolic proteasome-generated peptides across the membrane of the endoplasmic
reticulum (ER) for luminal delivery and loading of MHC-I molecules. Given the crucial role of TAP in translocating
peptides to MHC-I molecules, many clinically important human viruses such as Herpesviridae and Poxviridae
have evolved strategies to block TAP and evade host CD8 T cell recognition. TAP blockade upon infection of
dendritic cells (DC), which are responsible for naïve CD8 T cell priming, impairs conventional TAP-proteasome
processing for the classic MHC-I presentation of peptides to CD8 T cells. In fact, the current paradigm holds that
TAP blockade in DC renders these cells non-functional and incapable of priming a CD8 T cell response. Priming
virus-specific CD8 T cells falls on uninfected TAP-sufficient bystander DC through cross-presentation, a process
that enables MHC-I loading with viral peptides derived from DC internalized virus-infected dying cells. However,
CD8 T cells primed by TAP-sufficient DC recognize dominant TAP-dependent peptides, whose presentation is
severely reduced on tissues infected with immune evasive viruses. TAP-dependent CD8 T cells would also be
mismatched to the TAP-independent peptides liberated by alternative TAP-independent processing of viral
antigens and presented by MHC-I on those infected tissues. Either scenario creates a diminished or mismatched
CD8 T cell target. How does the immune system get around this problem? We found that DC without functional
TAP rely on cell-autonomous delivery of MHC-I from a new location, the ER-Golgi intermediate compartment
(ERGIC), to internalized antigens to rescue MHC-I presentation and nevertheless cross-prime CD8 T cells. We
call this pathway non-canonical cross-presentation. Our findings point to non-canonical cross-presentation as a
previously unrecognized pathway for priming CD8 T cells that recognize TAP-independent epitopes and would
be best-matched against immune evasive viruses. Studying non-canonical cross-presentation is important to
understand the full spectrum of CD8 T cells that can be mobilized against infection, especially if such T cells
provide potent local cross-protection within infected tissues. We seek to understand the role of non-canonical
cross-presentation in priming a TAP-independent CD8 T cell response against viral infection. Using novel models,
we will identify DC that conduct non-canonical cross-presentation, and define the repertoire of TAP-independent
epitopes they present to antigen-specific TAP-independent CD8 T cells. We will create novel tools to track TAP-
independent CD8 T cell responses and determine whether non-canonical cross-presentation can drive cross-
protective immunity against viral variants and immune evasive viruses. Understanding non-canonical cross-
presentation will inform universal vaccine design and new therapies for chronic and persistent viral infections.

Public health relevance
PROJECT NARRATIVE This project will study unique CD8 T cells that have the potential to confer cross-protection against different virus variants and immunity against persistent immune evasive viral infection. Understanding the requirements for the generation of these CD8 T cells, characterizing their phenotype and function, and creating new tools to track them during an immune response to infection is important to expand our immune armament against viruses. Our studies will inform the design of much needed universal vaccines against existing and emerging viruses, and guide new therapies for chronic viral infections.